Mechanics of Convective Cell Motion

Project Summary
Collective cell motion is involved in diverse physiological and pathological processes, from the separation of
tissues during early development, to tissue repair and cancer invasion in the adult. To date, collective motion is
predominantly associated with the mechanisms and driving forces that underlie single cell migration. During
migration, the cell undergoes a cyclic process of cell polarization and protrusion, adhesion to the extracellular
matrix (ECM) and the generation of traction forces. Though the transmission of mechanical stresses at cell-cell
junctions, the motion of a cell population becomes correlated over long distances and long times. However, cell-
cell interactions can also accumulate large mechanical stresses in the form of tissue pressures and surface
tensions. By force balance, gradients in these stresses can drive convection – mass transport due to bulk motion,
as occurs in fluids. Further, as the forces that arise from gradients in tissue-scale surface tensions and pressure
can be larger than those associated with single cell traction forces, ‘convective’ motions may be faster and more
correlated that what can be achieved by migration alone. However, despite the potential generality of this
phenomenon, how surface tension and pressure gradients are accumulated and transmitted within tissues is
unclear. Further, how convection and migration coordinate their diverse timescales and lengthscales to yield
complex cellular motions within is also unknown. This proposal seeks to identify the principles that underly
convection, its coordination with migration, and its role in physiological processes. Identification of these
principles will yield fundamental insights in biological mechanism, but also suggest novel targets for intervention
in motility-associated diseases.

Public health relevance
PROJECT NARRATIVE The collective motion of cells is essential, from the separation of tissues during early developmental processes to the maintenance and renewal of adult tissue. To date, collective motion is principally attributed to the concerted migration of cells with respect to their surroundings. The proposed research will illuminate how large- scale gradients in tissue surface tension and pressure drive motion through migration-independent mechanisms, demonstrating new mechanisms that underlie morphogenesis and cancer.